Regulation of Ferroptosis by the p53/CDK/Rb Axis.

Project Summary/Abstract:
Many types of cancer are still detected to late to be effectively treated. Therefore, new systemic therapies for
cancer are required. In our parent application we proposed to investigate the cell death mechanism called
ferroptosis as a potential means to kill cancer cells. Our studies were focused on understanding important
cellular pathways that modulate ferroptosis to uncover better mechansism to specifically target cancer cells.
While our work was underway, damage to the HVAC system in our building resulted in flooding of a
neighboring labortory. As a result, that lab will relocate to another location in the building and will remove an
ultralow (-80°C) freezer that my lab was using to store samples. This freezer is essential to store bacterial
stocks, cell lysates, protein samples among other important reagents. The purpose of this administrative
supplement is to seeks funds to purchase an ultralow -80°C freezer so that our research may continue without
major disruption.

Public health relevance
Project Narrative: This is an administrative supplement to a parent application in which we are investigating the mechanisms by which p53, CDKs and Rb regulate a unique cell death process called ferroptosis. Ferroptosis is under study as a means to treat cancer. In this supplement we are seeking funds to purchase an ultra-low freezer to continue our research.